Train and EMPOWER A Community Health workforce to achieve equity and reduce disparities in mental health (TEACH)

PROJECT SUMMARY
Lack of diversity among the workforce is a significant contributor to disparities in quality of care for racial and
ethnic minority populations and represents a major obstacle to meaningfully addressing the social
determinants of poor mental health in these population groups. Several key barriers to ensuring a
representative mental health workforce and improving access to quality care include: the massive shortage
and inequitable distribution of skilled providers; the high cost and lack of scalability of training and supervision;
the lack of delivery channels acceptable to recipients; and the lack of attention to social determinants. To
address this, the TEACH study will implement a scalable task-sharing model aimed at building capacity and
supporting a racially diverse workforce of non-specialist providers to deliver brief interventions for the indicated
prevention and early intervention for depression and anxiety, combined with new content tailored to the local
context in low resource, racial and ethnically diverse settings with emphasis on assessing and addressing the
social determinants of mental health in these communities, ultimately contributing to the reduction of disparities
in their communities. The proposed diversity supplement will complement the larger project and will train an
early career researcher in implementation science methodology, training and intervention development, and
grantsmanship in order for her to gain research independence.

Public health relevance
PROJECT NARRATIVE The proposed study will complement the larger project and will train an early career researcher in implementation science methodology, training and intervention development, and grantsmanship in order for her to gain research independence. The parent project, and by extension, the proposed project, aims to transform mental health care by addressing both supply and demand side barriers through provision of accessible and evidence-based care delivered by racially and culturally congruent providers; enabling care to be delivered regardless of a formal diagnosis; and empowering majority-minority, mostly first-generation college-attending students to acquire the skills to respond and become change agents for their communities. The proposed project will not only act as an immersive career development and training experience for the applicant, but will create an intervention for trauma-focused care in an emergency medical setting that has important implications for further dissemination and widespread understanding of the organizational and contextual factors which act as barriers to implementation of evidence-based interventions and can serve as a blueprint for broader scope and reach of mental health care to address the mental health needs of racial and ethnic minority groups in low resourced communities who experience disparities in access and outcomes.